Neuroinflammation, Perineural Nets, and Postoperative Delirium

The aging brain is associated with an increased risk of developing postoperative delirium (POD), postoperative
neurocognitive disorder (PNCD), and Alzheimer’s disease. POD occurs in 9-50% of older patients undergoing
anesthesia and surgery and is associated with a high risk of developing Alzheimer’s Disease and Related
Dementias (ADRD), greater incidences of postoperative complications, worse clinical outcomes, and higher
mortality. Heightened neuroinflammation is one of the key drivers underlying age-related POD. Existing research
on POD primarily focuses on glial cells and neurons, with little attention paid to the extracellular matrix(ECM).
Cells in the body constantly communicate with other cells and with ECM. It has become increasingly recognized
that ECM provides not only essential physical scaffolding for the cellular constituents but also initiates crucial
biochemical and biomechanical cues that are of utmost functional importance. However, whether ECM is
implicated in POD has yet to be examined. Perineural nets (PNNs) are ECM with chondroitin sulfate
proteoglycan-containing structures surrounding the soma and dendrites of various types of mammalian neurons.
We found that older mice displayed accentuated neuroinflammation characterized by increased Iba-1 expression
as well as decreased PNNs using WFA staining. Microglia depletion using PLX3397 prevented the degradation
of PNNs and deterred the occurrence of POD, suggesting microglia-mediated PNNs degradation as a
neuroinflammation mechanism underlying POD. To directly interrogate neuronal activities in POD, we
established intravital multi-photon microscopy in the hippocampus. Older mice after anesthesia and surgery
demonstrated exaggerated excitatory neuron activities. In contrast, parvalbumin (PV) interneurons, a key
subtype of inhibitory neurons which are often surrounded by PNNs, displayed decreased neuronal activities in
older mice after anesthesia and surgery, revealing excitatory/inhibitory imbalance linked to POD. Based on these
results, we hypothesize that neuroinflammation accompanied by anesthesia and surgery promotes PNNs
degradation which leads to neuronal dysfunction and age-related POD development. We plan to carry out
three interrelated but not interdependent Aims to rigorously test this hypothesis. Aim 1: To investigate the
kinetics of neuroinflammation-mediated PNNs degradation after anesthesia and surgery. Aim 2: To examine if
depleting PNNs surrounding PV interneurons could precipitate POD. Aim 3: To prevent POD by attenuating
neuroinflammation-induced PNNs degradation. Taken together, this proposal uses multidisciplinary tools
including intravital multi-photon imaging, genetic manipulation (microglia depletion, neuron-specific ChABC,
Hapln1 expression, etc.), biochemistry, and animal behavior, to dissect a previously unknown role for PNNs
(ECM) in the pathogenesis of POD, which provides novel mechanistic insights and therapeutic targets for POD,
a condition related to ADRD.

Public health relevance
The aging brain is associated with increased risk of developing postoperative delirium (POD), postoperative neurocognitive disorder, and Alzheimer’s disease. POD occurs in 9-50% older patients undergoing anesthesia and surgery, and is associated with high risk of developing Alzheimer’s Disease and Related Dementias (ADRD), worse clinical outcomes, and higher mortality. This proposal uses multidisciplinary tools including intravital multi- photon imaging, genetic manipulation, biochemistry, and animal behavior, to dissect a previously unknown role for PNNs in the pathogenesis of POD, which provides novel mechanistic insights and therapeutic targets for POD, a condition related to ADRD.